SibACCESS: Developing a Telehealth Intervention to Address Unmet Psychosocial Needs of Siblings of Children with Cancer

PROJECT SUMMARY/ABSTRACT
Childhood cancer leads to extended disruptions within family systems, which can leave siblings feeling
disconnected from their families and left to cope with strong cancer-related emotions on their own. Siblings
frequently report high levels of negative emotions and posttraumatic stress, which can interfere with their
behavioral functioning, interpersonal relationships, and ability to attend and concentrate at school. Outcomes
are worse for siblings from under-represented minority groups and for those with fewer socioeconomic
resources. The importance of attending to siblings’ psychosocial needs has been documented in over one
hundred studies and has been designated as a standard of care in pediatric oncology. Yet, this standard of
care is rarely met. Our pilot data highlights families’ desire for better sibling support, but there are no well-
established interventions tailored to siblings of youth with cancer. Most health care centers do not offer sibling
programs, and the few existing sibling interventions are poorly matched to siblings’ clinical presentations.
Furthermore, most supportive programs in childhood cancer insufficiently consider cultural differences in
families’ preferences regarding the goals, content, or format of supportive interventions. Siblings’ likelihood of
getting much-needed support is further limited by their absence from the hospital, where most supportive
programs for children with cancer and their families are based. The proposed research aims to address these
problems in clinical practice by developing a new culturally-informed psychosocial intervention guided by the
pediatric medical traumatic stress framework that addresses systematic barriers to supporting siblings by using
a telehealth approach. Specific aims are to (1) develop the SibACCESS (Acceptance, Coping,
Communication, Engagement, and Social Support) program based on the trauma-focused CBT framework and
refine the program based on feedback from a diverse sample of English- and Spanish-speaking families of
children with cancer, and (2) conduct a pilot trial of the SibACCESS program to assess the preliminary
feasibility and acceptability of the intervention and the feasibility of the research procedures and materials in
preparation for future, larger-scale efficacy trials. Community stakeholders (siblings, parents, providers) have
contributed to the design and aims of the proposed work and will continue to take a central role across all
stages of research design, analysis, dissemination, and future directions. The proposed program is novel in its
grounding in the pediatric medical traumatic stress framework and associated focus on increasing siblings’
exposure to and processing of cancer-related cues. By addressing sibling-specific barriers to care and
targeting siblings’ unique psychosocial needs, SibACCESS is expected to move us one step closer to meeting
the standard of care that calls for psychosocial services for siblings of youth with cancer. In turn, better sibling
support is expected to improve siblings’ psychosocial functioning over the lifespan, lessen the negative impact
of sibling adjustment problems on families, and overall, reduce the burden of pediatric cancer on families.

Public health relevance
PROJECT NARRATIVE Despite well-documented psychosocial risk in siblings of youth with cancer and families’ desire for better sibling support, there are no well-established interventions tailored to siblings of youth with cancer. The proposed research aims to develop and pilot test a culturally-informed psychosocial intervention guided by the pediatric medical traumatic stress framework that addresses systematic barriers to supporting siblings by using a telehealth approach. Better sibling support is expected to improve siblings’ psychosocial functioning over the lifespan, lessen the impact of sibling adjustment problems on families, and reduce the overall burden of pediatric cancer on families.